Designing and Implementing an Equity Planning Tool for International Research Partnerships

ABSTRACT
The Fogarty International Center is at the forefront of advancing National Institutes of Health (NIH) support for international research to promote health and reduce disease burden both in the US and globally. A large part of this mission is linked to the successful creation and maintenance of international partnerships between institutions and research groups in low- and middle-income countries (LMICs) and the United States (US). Successful collaboration among research partners - defined as the proactive and sustained prioritization of mutually beneficial inputs, processes, outcomes, and impact - is an ethical and practical imperative needed to achieve meaningful scientific aims and outputs within these partnerships. Despite the importance of establishing formal collaborative practices and several recommendations and guidelines available to do so, tools for systematically acknowledging existing partnership asymmetries and methods to overcome them are not well-described. The goal of this proposal is to develop and pilot a pragmatic collaboration tool using experienced HIV- focused research partnerships between Uganda, an LMIC, and the US as a case series given the dominance of the HIV epidemic on global health research paradigms over the past 40 years and the continued focus as a priority for many research partnerships in Uganda and the US. This will be accomplished through an explanatory quantitative to qualitative evaluation of these partnerships that generates a holistic understanding of best practices and barriers to collaborative research practices (Aim 1). These results will inform the creation of an ethics-informed collaboration tool that consists of structured survey and focus group materials to systematically evaluate an international research partnership and create a summative report that highlights exemplar practices, identifies feasible areas for improvement, generates attainable program-level goals, and creates an action plan (Aim 2). The tool will then be prospectively piloted and assessed for efficacy, feasibility, and acceptability within a research partnership (Aim 3). Collectively, this proposal seeks to elucidate a tool to recognize and, importantly, rectify barriers and instigate change at a program level within international research partnerships. This K01 will provide Dr. Chelsea Modlin with the training she requires in advanced qualitative and ethnographic methods including reflexivity, empiric and applied methods in international research ethics, and developing global health program assessment tools. This award will also support preliminary research findings needed to pursue R01 funding to scale up the collaboration tool to other geographic areas and fields of global health research. This tool has the potential to assist with ensuring that the ongoing research practices, outputs, and legacies of international research collaborations benefit both research partners and ultimately, the global communities they serve.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT / PROJECT NARRATIVE Health research in low- and middle-income countries (LMICs) is often conducted in collaboration with investigators and institutions in high-income countries with the rationale that this helps circumvent many of the structural and economic limitations faced by LMIC-based researchers and promotes local research priorities and findings to the benefit people globally. However, there is growing attention to the fact that international research partnerships may often inadvertently perpetuate academic and scientific asymmetries between research partners which ultimately risks suboptimal and inefficient scientific outcomes. Here we use experienced HIV-focused research partnerships between Uganda and the United States to comprehensively describe best practices and barriers to collaborative research and pilot an ethics-informed tool to guide international research partnerships toward optimal outputs.